Role of alveolar macrophage in omega-3 fatty acid amelioration of silica-triggered autoimmunity.

Summary: "Role of Alveolar Macrophage in Omega-3 Fatty acid Amelioration of Silica-Triggered
Autoimmunity”
While heredity is a primary predisposing factor for autoimmunity, cumulative exposures to
environmental factors such as toxic stressors and diet greatly impact latency and severity
autoimmune diseases such as lupus. Our goal is to understand how lupus triggering by an
ubiquitous environmental toxicant can be prevented by dietary modulation of cellular lipids. This
goal is predicated on preliminary studies revealing that 1)airway exposure to crystalline silica, a
recognized autoimmune disease risk factor, triggers early onset of systemic autoimmunity and
glomerulonephritis in the lupus-prone female NZBWF1 mouse and 2)supplementing their diets
with the omega-3 fatty acid docosahexaenoic acid (DHA), a well-known dietary supplement
extracted from cold-water fish, dose-dependently blocks this triggering. Here, we will employ in
vitro, ex vivo, and in vivo approaches to test the hypothesis that DHA consumption prevents silica-
triggered autoimmunity by suppressing inflammatory mediator production, death, and self-antigen
release in alveolar macrophages of NZBWF1 mice. Revealing DHA mechanisms against silica-
triggered lupus will bring novel insights into how respiratory toxicants initiate lupus and
subsequent flaring via lung as well as how manipulating cellular lipids through diet can be
exploited to prevent environmental triggering of human autoimmune disease.

Public health relevance
PROJECT NARRATIVE Autoimmune diseases (ADs) affect over 25 million Americans, inflicting tremendous individual suffering and societal burdens. Exposure to the earth’s most abundant mineral, crystalline silica (quartz), is common in individuals involved in construction, mining, farming, manufacturing and military deployment and increases their risk of developing systemic lupus erythematosus (lupus) and other ADs. Here we seek to understand the underlying mechanisms by which consumption of the omega-3 fatty acid docosahexaenoic acid (DHA) blocks silica-triggered lupus, thus yielding important new insights into how environmental toxicants trigger AD and how manipulating the lipidome through dietary fatty acid supplementation can prevent it.